Administrative Core

PROJECT SUMMARY – Administrative Core
The primary function of the Administrative Core (AC) of the RCMI@Morgan is to provide oversight of all program
activities including fiscal, budgetary, organizational, planning, evaluation, infrastructure development, and
technology transfer. The Core is responsible for the general administration, coordination, evaluation of all major
activities. AC also facilitates the implementation of Research Projects, Research Capacity Core (RCC),
Community Engagement Core (CEC), and Investigator Development Core (IDC) activities. In addition, the AC
provides leadership for conducting regular assessments to evaluate the program and identify needs and
opportunities, to seek insight and advice from the research advisory committees, and to create an integrated
work environment that fosters the development of high-impact research in health disparities. During the next 5
years the AC Specific Aims are to: 1) Provide leadership, administrative structure, management,
coordination, communication, and oversight of the entire range of RCMI@Morgan activities; by: (i)
implementing an integrated governance and management structure; (ii) providing day-to-day financial
management and coordinating all the activities and functions of the Center; and (iv) facilitating the
implementation of RCC, CEC, IDC and Research Projects activities; and (v) ensuring timely and effective
communication between the AC, RCC, IDC, and CEC leaders, research projects investigators, and NIMHD
program officials. 2) Provide administrative and logistical support and ensure proper fiscal and budgetary
management; by: (i) managing Core hires and training staff; (ii) prioritizing and allocating funds to other Core
activities; (iii) managing all purchases and travels; (iv) monitoring finances and preparing Federal Financial
Reports (FFRs). 3) Coordinate strategic activities that promote multidisciplinary research, community
engagement and biomedical career development; by: (i) Providing strategic direction and administrative
oversight to ensure that the Center activities are implemented in a timely manner; (ii) working with IDC to
implement strategic career development opportunities to early-stage investigators and other RCMI@Morgan
researchers; (iii) enhancing the capacity of MSU faculty to compete for extramural research grants; (iv)
strengthening collaborations and partnerships with RCMI Coordinating Center (RCMI-CC), National Research
Mentoring Network (NRMN), and CTSA. 4) Implement mechanisms that optimally enable the Center to
efficiently achieve its key outcomes and maximize its impacts; by: (i) working closely with the external
evaluator to conduct formative evaluations of all Center activities quarterly and perform summative evaluations
annually; (ii) identifying areas of concern and making data-driven recommendations for Program improvement;
(iii) tracking project status and level of productivity, and reporting to the research advisory board (RAB) and
NIMHD; and (v) working with RCMI-CC to develop common data elements (CDEs) and performance metrics for
systematic, broad-based evaluation of RCMI U54 Centers by NIMHD.